PROTEIN PROTEIN &PROTEIN LIGAND INTERACTIONS

Antifluorescein antibodies and partial protein constructs are being examined in order to isolate the primary conformational states and estimate the magnitude of the conformational substates involved in antibody-hapten interactions. A variety of monoclonal anti-heme antibodies will be examined spectroscopically to characterize the affinity to different porphyrin and heme groups. These measurements will include fluorescence polarization, steady-state fluorescence and CD-measurements. Using different porphyrins as haptens will allow us to determine the antigenic group for each Mab.